IGF::OT::IGF OTHER FUNCTIONS. Population Health Assessment in Cancer Center Catchment Areas Meeting. POP 10/30/17 - 4/13/18.

The Health Communication and Informatics Research Branch (in the Behavioral Research Program, NCI) has the following program support needs related to the Population Health Assessment in Cancer Center Catchment Areas Meeting, which is scheduled to take place on March 9, 2018 at the Albert Einstein Cancer Center (1300 Morris Park Ave, Bronx, NY). Approximately 100 people will attend this meeting